NEGLECTFUL MOTHERS'PERCEPTIONS OF THEIR BABIES

The proposed pilot study is designed to measure neglectful mother's perceptions of their babies. Thirty mothers diagnosed as Neglectful will complete the study. We anticipate that neglectful mothers will abnormally perceive their babies.